CRCNS: Interhemispheric coordination for memory and action

Virtually all research on brain communication at the level of individual neurons and small populations of
neurons has focused on inter-area communication within a hemisphere. While multi-area communication
is undoubtedly important for understanding neurological disorders and increasingly studied, such a
perspective ignores the more dramatic issue that brain processing occurs across two hemispheres. The
mechanisms by which information about the world is stored, processed, and acted upon by both
hemispheres are critical to much of higher brain function.
Assessing the fundamental principles of interhemispheric coordination has been challenging. However,
technical advances in multi-contact electrode technology and conceptual advances in dynamic attractor
modeling have allowed us to make significant progress in disentangling competing hypotheses regarding
how the prefrontal cortex organizes and represents memory and movements. These advances suggest
that prefrontal cortex is more modular and less distributed than previously thought such that each
hemisphere has a complete representation of visual space, including both left and right hemifields. The
apparent redundancy provides an important avenue for work focused on neurological rehabilitation and
restoration.
We propose experiments that will capitalize on recent advances and our collective expertise. Our first
specific aim will investigate the maintenance of spatial working memory across the hemifields in
populations of neurons in prefrontal cortex. Our second specific aim will investigate how memory is
transformed into a plan to move the eyes, focusing specifically on how interhemispheric spatial memory
influences a single action. The final specific aim is to model spatial working memory networks across the
two hemispheres, using the attractor network framework to simulate alternative architectures for brain
function. Collectively, these experiments will provide new insights into the mechanisms that underlie
critical brain processing circuits that are central to a host of everyday behaviors and neurological
disorders.

Public health relevance
Communication across the hemispheres of the brain is critical for numerous brain functions and especially fundamental to the storage and retrieval of spatial memory. To better diagnose and treat disorders of the brain in which communication is impaired it is critical to understand how the hemispheres of the brain communicate and how that communication impacts behavior.